INCIDENCE OF VON WILLEBRAND'S DISEASE IN PEDIATRIC PATIENTS WITH CAT AND CH

The aim of this study is to determine the incidence of symptomatic and asymptomatic acquired Von Willebrand's disease associated with acquired chronic auto-immune thyroiditis and with congenital hypothyroidism.